Structural studies of chromatin complexes

Project Summary/Abstract
The nucleosome is the hub of signals that regulate gene expression in eukaryotic cells. An important
mechanism of such regulation is the post-translational modification of the histone protein components of the
nucleosome. However, we possess only a rudimentary mechanistic understanding for how these modifications
are installed on the physiological nucleosome substrates by histone modification enzymes and subsequently
read by epigenetic reader proteins. These shortcomings limit our ability to interpret the wealth of genetic,
genomic and biochemical data available, and they hamper development of new therapeutics that target
epigenetic chromatin enzymes and readers associated with human diseases including cancer. We are
focused on addressing these deficiencies through structural and biochemical studies of histone modification
enzymes and readers in complex with the nucleosome. We leverage structural models produced using
cryoelectron microscopy to develop mechanistic hypotheses and then challenge these models through
nucleosome-based binding and enzymatic assays. Our studies of epigenetic histone modification enzymes
and readers should impact both our basic science understanding of gene regulation and therapeutics for
human diseases.

Public health relevance
Project Narrative In our cells, our DNA genetic information is packaged with histone proteins into chromatin. Recent studies have shown that histone proteins can be decorated by histone modification enzymes with small molecules or proteins, and these decorations can be recognized by reader proteins to regulate gene expression in normal and diseased cells. Our studies will visualize how different histone modification enzymes and reader proteins associated with stem cells and cancer perform their functions.